MOLECULAR GENETICS MEETING

The proposed conference on mouse molecular genetics will gather together scientists studying the control and functions of genes in various processes assessed in the context of using the mouse as an experimental system for studying mammalian development and disease. Central to the scope of this meeting is modifying the germ line of mice through the introduction of new genetic information (via pronuclear microinjection) or the alteration (or ablation) of existing genetic information (via targeted integration in embryonic stem cells). The timely exchange of results, approaches and technological developments in this rapidly moving field are central to its progress and thus warrant a specialized meeting with this focus. This fifth annual "Mouse Molecular Genetics" meeting is scheduled to be held in Cold Spring Harbor, August 26-30 and is expected to attract about 350 scientists working on various aspects of the molecular biology and molecular genetics of the mouse. The emphasis of the meeting will be on the mouse as an organism (as opposed to in vitro studies) and will cover such areas as: regulation of gene expression in development, pattern formation in development, roles of receptors and their signals, cell proliferation and oncogenesis, models of disease processes, and molecular analysis of mutations. The meeting is intended for students and postdocs as well as established investigators. All applicants will be expected to submit an abstract. About one third of the abstracts will be selected for 10 minute talks along with the invited speakers, and the rest will presented as posters. The abstracts will be collated into a booklet that will be available to all attendees, but the proceedings will not be published. This has been an increasingly successful meeting over the last four years, and we feel that it fulfills a very important role by facilitating cross communication between various disciplines in the use of mice to study mammalian biology and disease.